Project 2 - Longitudinal study of complement-mediated TMA

PROJECT SUMMARY – PROJECT 2
The overall goal of this project is to develop the first multicenter, prospective, longitudinal natural history study
of complement-mediated TMA (CM-TMA also called atypical hemolytic uremic syndrome) to comprehensively
investigate short- and long-term outcomes including renal, cardiovascular, neurologic, and patient reported
outcomes. In CM-TMA, excessive complement activation triggers inflammation, platelet activation and direct
endothelial injury causing microvascular thrombosis. CM-TMA is considered a genetic disease – up to 50% of
patients harbor rare germline variants in complement genes; however, complement mutations are neither
necessary nor sufficient to cause disease. The penetrance of these variants in only ≈ 20% and complement
amplifying conditions (pregnancy, infection, autoimmunity, and malignancy) often trigger CM-TMA. We have
developed a cell-based assay that measures complement-mediated cell injury induced by patient serum and
can distinguish CM-TMA from other TMAs. We recently established an improved and commercially scalable
version of the assay called the bioluminescent modified Ham assay. Using this ‘biosensor’ with pathway
specific inhibitors, we showed that complement activation in CM-HUS is predominantly driven by autoreactive
IgM that activates the classical pathway, with mutations in the alternative pathway predisposing to additional
complement dysregulation. This is a paradigm shift since CM-CMA was considered a disorder of primary
alternative complement pathway dysregulation for over 50 years. Terminal complement inhibitors have
drastically reduced risk of end-stage renal disease and death from acute TMA. However, little is known about
long-term renal and extra-renal outcomes such as rates of progressive renal disease, cardiovascular disease
and hypertension that have never been systematically and prospectively evaluated.
With the large USTMA
consortium with 22 high-volume clinical sites, and our novel, scalable and commercially feasible
bioluminescent modified Ham assay, this proposal will answer the most pressing questions in CM-TMA today:
(1) what are the long-term renal, cardiovascular, and neurologic outcomes of CM-TMA? (2) does functional
complement activation during TMA remission (measured by the bio-mHam) or the presence of complement
mutations increase the risk of these adverse long-term sequelae, and (3) develop a repository to facilitate
using the bio-mHam to functionally interrogate the role of complement in secondary TMA, and the significance
variants of uncertain significance, both which are areas of uncertainty. In aim 1 of this project, we will develop a
longitudinal registry of adults and children with CM-TMA to evaluate the long-term clinical outcomes,
complications and comorbidities, including performing serial brain MRI to detect subclinical ischemic injury in a
subset of participants. In aim 2, we will evaluate whether persistent complement activation during CM-TMA
clinical remission is associated with relapse risk, decline in renal function, and cardiovascular disease.